Tissue Specific Impact of Organic Cations on Mitochondrial Energy Transduction

PROJECT SUMMARY/ABSTRACT
Drug side effects and more severe drug induced injuries are complex multifactorial processes that pose a
significant barrier to prescription drug use and design. The gastrointestinal and hepatobiliary systems are the
‘first pass’ of drug absorption and metabolism, resulting in disproportionate occurrences of side effects/toxicities
in these tissues. Additionally, highly perfused tissues, such as the heart, are also disproportionately implicated.
Mounting evidence suggests that a substantial proportion of common drugs (~10-40%) can modulate
mitochondrial energy transduction, highlighting this organelle as an important area of focus. Mitochondria are
central to cellular function, as such, small modifications of mitochondrial energy transduction can lead to dramatic
changes ranging from altered physiological function to cell death. Emerging evidence suggests that mitochondria
from different tissues exhibit bioenergetic phenotypic characteristics that are intrinsically related to the metabolic
demands of their source tissue. Additional evidence suggests that mitochondria isolated from different tissues
are sensitive to chemical interactions in distinct ways. This is important because this effect may be a significant
component of drug side effects/toxicities and may even contribute to the primary mechanisms of action for some
drugs. In our preliminary testing we discovered that a common class of drugs, organic cations (i.e. those that
carry a net positive charge at physiological pH), accumulate at high concentrations in mitochondria and dose
dependently alter mitochondrial respiration and membrane potential in a manner that is (in many cases) tissue
specific. From those observations we developed the central hypothesis that that tissue specific mitochondrial
bioenergetic phenotypes predispose interactions between organic cation drugs and the respiratory system. To
test this hypothesis, we will implement an integrative workflow that leverages our unique mitochondrial
phenotyping capabilities in conjunction with mitochondrial proteomics and multivariate statistical analysis to
complete the following research aims: 1.) Quantitatively define mitochondrial structure-function relationships in
gastrointestinal, hepatic, and cardiac tissues. 2.) Test for tissue specific interactions using a representative panel
of organic cation drugs and define specific protein targets associated with the interactions. The completion of
these aims will address a critical knowledge gap pertaining to the functional and structural correlates that drive
drug interactions with the mitochondrial energy transduction system in tissues that are disproportionately affected
by drug side effects/toxicity. The accompanying training plan is designed to prepare the PI (Dr. Schmidt) for a
transition to an independent academic faculty position in a medical school. The training will be carried out in a
state-of-the-art multi-disciplinary institute (East Carolina Diabetes and Obesity Institute), with the support of a
diverse mentoring team with collective experience in physiology, bioenergetics, biochemistry, and applied
mathematics.

Public health relevance
PROJECT NARRATIVE Many commonly prescribed drugs induce significant side effects and/or toxicity disproportionately in some tissues. Emerging evidence suggests that mitochondria, a critical subcellular organelle that are enriched in metabolically active tissues, may be particularly sensitive to drug interactions resulting in a range of complex physiological effects. The proposed studies will determine specific details of drug interactions with mitochondria and cells isolated from different tissues, and identify potential mediators of the effects that can be targeted to improve drug design and reduce tissue specific side effects/toxicities.